ABERRANT BEHAVIOR AND FRAGILE X MENTAL RETARDATION PROTEIN IN NEUROANATOMY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Fragile X syndrome provides a model for elucidating critical linkages among gene, brain, and cognition in children with serious neurodevelopmental disorders. Specific Aims: To determine how neuroanatomic variation in children and adolescents with fragile X syndrome is linked to reduced levels of the fragile X mental retardation-1 protein and to aberrant cognition and behavior. Methods: In 84 children and adolescents with the fragile X and 72 controls matched for age and sex, brain morphology was assessed with volumetric, voxel-based, and surface-based modeling approaches.